MYCN drives a ferroptotic vulnerability in neuroblastoma

Summary: Apoptosis is a type of programmed cell death and has for a long time been appreciated to be a
hallmark of cancer cells. In recent years, drugs targeting the apoptotic pathway, such as the FDA-approved
BCL-2 inhibitor, venetoclax, have revolutionized therapy in cancers which have a particular vulnerability to
targeting this pathway. A different programmed cell death pathway, ferroptosis, has recently been discovered.
Understanding which cancers may be vulnerable to the induction of ferroptosis and which targetable molecules
are involved could lead to a new wave of successful cancer therapy. MYCN-amplified neuroblastoma (NB) is
one of the deadliest subtypes of pediatric cancer. Here in, we demonstrate that amplified MYCN drives an
aberrant iron capture program in NB and increases intracellular cysteine biosynthesis and selenocysteine
dependence through multiple mechanisms to detoxify reactive oxygen species (ROS) accumulation as a result
of high cellular iron. The consequence of these MYCN-directed changes is a synthetic lethality to genetic or
pharmaceutical targeting of the glutathione/glutathione peroxidase 4 (GPX4) pathway resulting in ferroptotic
cell death. This grant aims to expand our understanding of how MYCN alters cysteine and selenocysteine
production and ferroptotic inducing pathways to sustain an antioxidant defense and how these pathways may
be exploited pharmaceutically to improve therapeutic responses in this recalcitrant tumor type.
Specific Aims:
Aim 1: Characterize the ability of MYCN to suppress ferroptosis in neuroblastoma
Aim 2: Identification of synthetic lethal ferroptosis resistance mechanisms in MYCN-amplified neuroblastoma
Aim 3: In MYCN-amplified neuroblastoma mouse models, evaluate novel ferroptotic combination therapies
Study Design: Using well isogenic cell lines and patient-derived xenograft cell cultures, we will mobilize
expertise in selenocysteine biosynthesis (Copeland), pantothenate kinase inhibitors (Rock), and genomic
screening of ferroptotic pathway modifiers (Olzmann) to better define the ferroptotic vulnerability in MYCN-
amplified NB and to uncover novel sensitizers to ferroptotic inducers in MYCN-amplified NB. The goal of these
experiments is to not only better understand how the MYCN oncogene hijacks cysteine for selenocysteine
production to mount a defense against an oxidized phenotype, but to create new therapeutics to create better
anti-ferroptotic approaches in MYCN-amplified NB. To this end, we will work with our preclinical mouse model
expert (Koblinski) and a NB clinical investigator (Glod) to build the preclinical evidence of synthetic lethal new
therapies into the clinic for refractory NB patients. Recently, inhibiting telomerase was demonstrated to induce
ferroptosis. We propose to expand our investigations of inhibiting telomerase with clinically-advanced
telomerase inhibitors in combination with canonical ferroptosis inducers, as this presents an intriguingly new –
and clinically advanced—strategy to take advantage of the ferroptosis vulnerability in MYCN-amplified NB.

Public health relevance
Project Narrative The oncogenic transcription factor MYCN drives a subset of deadly neuroblastoma and remains undruggable; therefore, finding synthetic lethal relationships that may result in new treatments is one of the “holy grails” of pediatric cancer therapy. In the parent grant proposal, we provide evidence that amplified MYCN orchestrates a complex and intricate re-wiring of the neuroblastoma cell to 1) increase iron metabolism, 2) increase cysteine and selenocysteine biosynthesis to counteract reactive oxygen species created from iron metabolism-related Fenton reactions and 3) increase synthesis of pantothenate kinase 3 (PANK3) to subsequently increase coA levels; the result of which is the creation of a synthetic lethality and therapeutic vulnerability to ferroptosis induction which we aim to explore, clarify and translate to new therapeutic options for this recalcitrant pediatric tumor. In this diversity supplement, we will expand our investigations based on newly published data that telomerase inhibitors are potent ferroptosis inducers, and further rooted in the understanding that telomerase is a key MYCN-driven dysfunctional pathway in neuroblastoma, we will determine the efficacy of clinically- advanced telomerase inhibitors in combination with canonical Ferroptosis inducers.